Self-immolative prodrug/miRNA nanoparticle combinations for cancer treatment

The goal of this proposal is to improve systemic therapies of colon cancer using self-assembled nanomaterials
that can deliver potent anticancer miRNA and then degrade in cancer cells to active small molecule modulators
of dysregulated polyamine metabolism. Despite tremendous therapeutic potential, clinical translation of miRNA
faces major unsolved pharmaceutical delivery challenges. Due to the involvement of multiple mutations in
tumorigenesis and tumor progression, combination of miRNAs with modulators of polyamine metabolism has
significant therapeutic potential. The fact that polyamine metabolism is downstream from many oncogenes and
tumor suppressor pathways make it a logical target for such combination miRNA therapy approaches. Our
objective is to develop polyamine prodrugs (PaPs) that can modulate dysregulated polyamine metabolism and
encapsulate and systemically deliver anticancer miR-34a. The hypothesis is that self-immolative PaPs based on
modulators of polyamine metabolism will deliver miR-34a to the tumors, which will result in enhanced
combination effect due to the downregulation of tumor polyamine biosynthesis and upregulation of polyamine catabolism
and restoration of important cell growth and death-regulatory functions due to miR-34a. We will accomplish the
objectives in three specific aims: (1) we will optimize formulation of tumor-penetrating PaP/miR-34a
nanoparticles that deliver miRNA and modulate polyamine metabolism. Based on encouraging anticancer in vivo activity
in our preliminary studies, we hypothesize that particle modification with tumor-penetrating iRGD peptide and
with stabilizing superhydrophobic fluorinated moieties will result in efficient systemic delivery. (2) we will
determine the mechanism of action of PaP/miR-34a nanoparticles in vitro. Our results indicate that PaPs are effective
in reducing tumor cell growth and induction of apoptosis, but the precise mechanism of action of the
nanoparticles and how it relates to their intracellular trafficking, disassembly and rate of polyamine analog release is
unknown. We will ascertain the mechanisms of action and determine which composition strategies are most
effective in producing strong antitumor effect. (3) we will test the in vivo efficacy of the particles in colon cancer
using human tumor xenografts and syngeneic immune competent tumor models. We will conduct comprehensive
evaluation of anticancer activity and survival advantage of PaP/miR-34a in models relevant for human disease.
Contribution of the antitumor immunogenicity to the efficacy will be also studied due to known effects of
polyamine analogs on increasing the antitumor immune response. We predict that we will be able to prepare
nanoparticles with improved anticancer activity and prolonged survival. The proposed integrative approach is innovative
because of the dual-function design of the PaP polymers as modulators of polyamine metabolism and miRNA
carriers. The research is significant because it will address major barriers in developing drug/nucleic acid
nanotechnology for systemic treatment of cancer and establish a widely applicable and versatile platform for
combination delivery systems that target polyamine metabolism as a way of improving anticancer therapies.

Public health relevance
The proposed research focuses on innovative combination delivery strategy of therapeutic miRNA to treat colon cancer, which despite treatment advances, remains a major cancer killer in both women and men in the U.S. We will develop self-assembled tumor-penetrating nanoparticles that release miRNA inside cancer cells and then degrade into small molecules that modulate dysregulated polyamine metabolism in cancer to boost the therapeutic miRNA activity. Our approach will contribute to fundamental understanding of systemic delivery of self-assembled nanoparticles and innovatively address problems in the delivery of drug/miRNA combinations to improve colon cancer therapy.